Administrative and Research Support Core

Project Summary
The overarching goal of the Administrative and Research Support Core (Core A) of the Michigan Center on the
Demography of Aging Center (MiCDA) is to provide administrative and research support to Center activities in
order to promote new research on the demography of aging. MiCDA’s focus over the next cycle will emphasize
two overarching thematic areas: the changing demography of late-life disability, dementia and family caregiving;
and the social, environmental and biological underpinnings over the life course that shape later-life health and
wellbeing. A third theme, cross-cuts the two substantive foci, by advancing data infrastructure and methods to
promote breakthroughs in the demography of aging. Core A supports MiCDA activities through two main sets of
tasks: (1) Planning and executing administrative functions for MiCDA’s core activities including: overseeing
administrative aspects of MiCDA’s Emerging Scholars Mentored Pilot Project Program and accompanying
mentorship curriculum; handling event planning, travel and hosting for MiCDA’s meetings, research conferences,
webinars, symposia and network meetings; coordinating purchases, agreements and other administrative needs
of the MiCDA secure virtual data enclave; and adding new affiliates; and (2) Collecting and analyzing relevant
information to evaluate activities with Core Leaders; leading visioning and evaluation activities and regularly
reporting to MiCDA’s Advisory Panel; and preparing reports to the Coordinating Center and the National Institute
on Aging.